DOSE ESCALATION STUDY OF TWICE DAILY RADIOTHERAPY FOR LUNG CANCER

The primary objective of this study is to determine the highest dose of radiation that may be delivered to the lungs using twice daily radiotherapy and three-dimensional treatment planning. Radiation for the treatment of lung cancer is usually given once daily. In this study, the radiation will be given twice-daily to allow for a greater dose of radiation to be delivered in a shorter span of time. Another objective of this study is to test the use of a radiotherapy planning system called three-dimensional conformal planning (3-D). By precisely targeting the tumor while minimizing treatment of normal tissue, it is hoped that tumor control may be improved without increasing side effects.